Combinatorial effects of PTMs on a-Synuclein structure, function and aggregation

α-Synuclein is a small neuronal protein that is the primary component of the proteinaceous aggregates that are the hallmark of Parkinson’s disease (PD), Lewy body dementia (LBD), multiple system atrophy (MSA) and other synucleinopathies, as well as being implicated in related neurodegenerative diseases such as Alzheimer’s disease. Despite intense study, an understanding of the environmental factors which lead to αS aggregation in PD and to differences in aggregation in LBD and MSA is still lacking. Recent evidence supports the idea that structural differences between α-Synuclein aggregates, or ‘strains’, underlie different synucleinopathies. While the molecular details are not yet well understood, it has been suggested that post-translational modifications to α-Synuclein may underlie conformational differences between ‘strains’. However, understanding how these modifications impact aggregate structure, and ultimately pathology, is extremely challenging, both given the large number of reported post-translational modifications to α-Synuclein, as well as their heterogeneous distribution in patient derived samples. From a biochemical and biophysical perspective, many of these modifications have been addressed individually and found to have striking impacts on α-Synuclein properties, including aggregation kinetics and cellular uptake and seeding. However, there is a significant gap in our understanding of how multiple simultaneous modifications may work cooperatively to alter aggregate structure or α-Synuclein function. Our proposed research will address this deficit by taking advantage of the collective expertise of the three PIs in protein chemical synthesis, cellular and molecular biophysics, and structural biology. This will include using a novel semi-synthesis strategy – combining unnatural amino acid mutagenesis, chemoenzymatic modification, thiol-ene reactions, and native chemical ligation – to produce α-Synuclein site specifically modified both at single and multiple sites (Aim 1); determining the impact of α-Synuclein modifications on functional interactions with lipid bilayers, on the kinetics of self-association and on the structural features of the aggregates (Aim 2); and relating these structural effects to internalization of α-Synuclein by primary neurons, and subsequent seeded aggregation of endogenous α-Synuclein (Aim 3). We have selected seven different disease-associated sites on α-Synuclein that are subject to modification with diverse groups, including phosphorylation, acetylation and ubiquitination, and we will compare and contrast the individual effects of these modifications as well as their cross-talk. Our focus is on modifications that are differentially found in PD, LBD, and MSA patient tissues and for which available structural data allow us to propose clear mechanistic hypotheses. We expect to characterize the impact of these modifications both on α-Synuclein functional interactions as well as fibrillar structure and spread. The resulting impact will be in providing a thorough understanding of the molecular basis of ‘strain’ differences in synucleinopathies and guiding the development of therapies targeted at post-translational modifications, or even entirely new therapeutic strategies for synucleinopathies and related dementias.

Public health relevance
Project Narrative The aggregation of α-Synuclein into fibrillar aggregates plays a pivotal role in the progression of Parkinson’s Disease and related neurodegenerative disorders. The proposed research will create α-Synuclein modified by chemical groups identified in post-mortem tissues and test the impact of these modifications both on functional and dysfunctional interactions of the protein. This research will provide insight into the relationship between the structural effects of these modifications on α-Synuclein and disease propagation.